Examination of epigenetic spatial architecture in the CNS as a method to understand cocaine relapse in ecoHIV infected mice

This proposal seeks to develop a new imaging pipeline that will examine tissue level and nuclear level
spatial architecture of histone dopaminylation in the CNS of ecoHIV infected mice allowed to self
administer cocaine. To achieve this goal we will develop a new imaging pipeline that that collects large
numbers of images (>15,000 per animal and brain region) and analyzes them using a novel AI-powered,
machine learning approach.
Substance use disorders (SUD) are a chronic disease of the CNS that are characterized by compulsive
craving that persists even after substance use ceases. The development of SUD is associated with a transition
in brain physiology that maintains drug seeking and taking. Epigenetics, the change in gene expression without
change to DNA sequence, and the underlying mechanisms of histone modification, transcription factor
recruitment and DNA packaging, is involved in an array of neurodegenerative diseases, including control of HIV
transcription. Furthermore, there is evidence that substance use drives changes in chromatin structure and
therefore may alter gene expression, and that these changes may play a role in relapse to drug use. Recent
studies have shown that dopamine can modify histones of cells in the CNS and that dopaminylation drives
cocaine seeking behavior in rodents. Techniques that can connect the available powerful single cell molecular
approaches and gross examination of the CNS by both traditional histology and modern non-invasive imaging
for the study of HIV and substance use have not been used extensively. We propose to address this technical
shortcoming by combining our strengths in epigenetics, high resolution imaging of the CNS, computational
biology and animal behavior. We will query sub-nuclear and tissue region architecture of epigenetic
modifications, including the newly discovered dopaminylation of histone H3 (H3Q5dop), analyze the resulting
data using a machine learning based pipeline, and then correlate this architecture to behavioral outcomes as
they relate to drug seeking behavior. In addition to the creation and testing of new technologies, we will address
the hypothesis that altered dopaminylation of histones in astrocytes is the mechanism by which HIV infection
enhances sensitivity to cocaine’s neurobehavioral properties. We develop our technology in the R61 exploratory
phase (Aim 1: Imaging of H3Q5dop and other epigenetic marks in nuclei isolated from mice self-administering
cocaine, Aim 2: Assess applicability of tissue clearing protocols to whole-tissue imaging of histone modification,
Aim 3: Determine applicability of NUCLEO-M and tissue clearing microscopy to existing tissue bank samples)
and fully test our behavioral hypothesis in the R33 application phase (Aim 4: Assess the independent and
interactive effects of cocaine exposure on nuclear architecture in a model of HIV infection, Aim 5: Determine the
contribution of dopaminylation to the regulation of cocaine seeking in a mouse model of HIV infection)

Public health relevance
Project Narrative There is a significant number of people living with HIV who are also substance users. Cocaine use represents a comorbidity that worsens the neurological outcomes of HIV infection. This study proposes to research the mechanisms that underlie altered addictive substance seeking behavior in persons living with HIV.